Role of Sphingolipids in KRAS induced lung adenocarcinoma

Project Summary/Abstract
We have analyzed Kras mutant lung adenocarcinoma and demonstrated that the cell of origin is
the alveolar Type II cell. Alveolar Type II cells undergo a Notch-dependent dedifferentiation to
bipotent progenitor cells. These cells have markers of both Type I and Type II cells and initiate
and propagate tumors both in vitro and in vivo. Thus, finding methods of inhibiting these cells
could quickly lead to important therapeutic advances for patients with KRAS mutant tumors.
Sphingolipid pathways downstream of Kras are promising therapeutic targets in these cells. In
the current application, we will use mechanistic and high throughput methods to test existing
drugs against 3-dimensional cultures of Kras mutant bipotent progenitor cells. We will also use
Cas/Crispr technology to identify sphingolipid genes and pathways that will be effective in
inhibiting these cells. Finally, because macrophages are intimately involved with the tumor
cells during initiation and progression and sphingolipids are involved in tumor immune
suppression, we will test unique inhibitors of immunosuppressive tumor macrophages and
sphingolipid inhibitors to allow immune surveillance of forming tumors. In addition, additive
mutations of p53 and Lkb1 which are common in lung adenocarcinoma will be used in all assays
so that the broad range of KRAS mutant lung adenocarcinomas will be addressed.

Public health relevance
Project Narrative KRAS mutant lung adenocarcinoma remains a challenging clinical problem without specific inhibitors. We have demonstrated that alveolar Type II cells become cancer stem cells when Kras is activated. We will analyze sphingolipid pathways in these cells to identify new therapeutic targets. We will also use gene editing technology (Cas/Crispr) to find sphingolipid genes that are necessary for the survival and growth of Kras mutant stem cells. Finally, we will test new methods of activating the immune system against these cells. These approaches should allow rapid translation to the clinic to help Veterans with KRAS mutant lung cancer.